Unraveling idiopathic pulmonary fibrosis endophenotypes; a lung-centric approach to prognostic and therapeutic biomarker validation

PROJECT SUMMARY/ABSTRACT
Idiopathic pulmonary fibrosis (IPF) presents a formidable challenge due to its complex pathology and the
limited efficacy of current therapeutic strategies. Traditionally treated as a homogenous entity based on
subjective clinical and radiological assessments, IPF's heterogeneity has been significantly underexplored,
resulting in a one-size-fits-all treatment approach that fails to improve long-term survival. Our preliminary data
has discovered unique inflammatory and hypoinflammatory endotypes within the IPF lung and lung
microenvironment, each associated with unique survival trajectories, underscoring the need for a molecularly
informed approach to IPF management.
We aim to validate and expand on these findings by leveraging a global biorepository of IPF bronchoalveolar
lavage fluid (BALF) and lung tissue samples. Our objective is to conduct an in-depth proteomic analysis to
confirm the prognostic relevance of these endotypes, particularly focusing on protein profiles linked to
autoinflammatory processes and immune cell signaling. These profiles, identified in our preliminary studies,
show a strong correlation with patient outcomes and provide a promising foundation for precision medicine in
IPF.
Specific Aim 1 will validate the prognostic significance of these proteomic clusters in a large cohort of IPF
patients and assess treatment response for each of the phenotypes to historic and current IPF treatment
strategies. Specific Aim 2 will validate these inflammatory and hypoinflammatory endotypes in IPF lung tissue
and explore pathways that define them with a particular focus on repurposing existing treatments such as
complement pathway inhibitors based on exciting preliminary data.
Our work is expected to lead to the establishment of a molecular classification system for IPF that informs
therapeutic decisions and guides patient stratification for personalized treatments. Additionally, we anticipate
discovering biomarkers that predict treatment responses, reducing exposure to ineffective therapies and
thereby enhancing quality of life and survival rates for IPF patients.
By combining cutting-edge systems biology with patient-centered research, this project is poised to transform
IPF management, offering an evidence-based framework for precision treatment strategies that align with each
patient’s unique molecular profile. Our findings have the potential for rapid translation into clinical practice,
providing a new paradigm in the diagnosis and treatment of IPF and offering hope for improved outcomes in
this devastating disease.

Public health relevance
PROJECT NARRATIVE This project seeks to revolutionize the treatment and prognosis of idiopathic pulmonary fibrosis (IPF) by validating distinct molecular endotypes within the IPF lung and lung microenvironment. Through comprehensive proteomic analysis of a global cohort, we aim to validate the presence of targetable inflammatory endotypes in IPF, enabling personalized therapeutic strategies on expedited timelines. Our approach promises to shift the paradigm from a one-size-fits-all model to precision medicine, significantly impacting patient outcomes in IPF.